Novel Roles for Phospholipids in Regulating Placental Function and in the Delivery of DHA to the Fetal Brain.

PROJECT SUMMARY
An adequate placental transfer of lipids is critical for normal fetal growth and brain development, yet the
mechanisms involved in placental lipid handling and transport are largely unknown. Many important
pregnancy complications such as intrauterine growth restriction (IUGR) and maternal diabetes are
associated with disturbances in fetal fat deposition that may contribute to adverse short-and long-term
outcomes. Although mechanistic links between placental lipid handling and transport, fetal fat deposition and
fetal brain development remain to be established, emerging evidence suggests that these pregnancy
complications are associated with altered placental lipid metabolism. The syncytiotrophoblast, the
transporting epithelium of the human placenta, mediates the transfer of lipids from the maternal to the fetal
circulation. There is now compelling evidence that complex lipid forms are produced in large amounts by the
syncytiotrophoblast and are potentially released to the fetus. In particular, primary human trophoblast cells
rapidly take up fatty acids and incorporate them to phospholipids. De novo synthesis and remodeling of
phospholipids generates a range of biologically active intermediates, including Phosphatidic Acid which
regulates mTOR signaling in cancer cells. Phospholipid remodeling generates Lysophosphatidylcholine
species containing docosahexaenoic acid (LPC-DHA) which is the predominant form in which DHA is
transported across the blood brain barrier, mediated by MajorFacilitator Superfamily Domain Containing 2A
(MFSD2a),an LPC-DHA transporter. We found high levels of LPC-DHA in placental tissue and that umbilical
vein LPC-DHA levels are higher than maternal circulating concentrations, suggesting that DHA is delivered to
the fetus as LPC-DHA. In addition, we discovered that MFSD2a is expressed in the human
syncytiotrophoblast basal plasma membrane, consistent with the possibility that this transporter mediates
transfer of LPC-DHA to the fetus. These observations provide the premise for our central hypothesis that
trophoblast phospholipid synthesis and remodeling are highly active, produces phosphatidic acid (which
modulates TOR signaling) and LPC-DHA for transport to the fetus, mediated by MFSD2a. Our hypothesis is
supported by compelling preliminary data including evidence that phosphatidic acid regulates placental
amino acid transport mediated through mTOR signaling and LPC-DHA is produced in placenta and released
to the fetus. We will use human placental tissue, maternal and umbilical blood samples collected from normal
and complicated pregnancies, siRNA gene targeting approaches in cultured primary human trophoblast cells
incubated in a physiological mixture of 13C-stable isotope labelled fatty acids and trophoblast specific gene
targeting in mice to address this hypothesis. These
mechanistic
placental
studies are highly significant because we will use nove
approaches to establish that phospholipid synthesis intermediates are important regulators of
function and critical mediators of placental transfer of DHA, essential for normal brain development.
l

Public health relevance
Project Narrative Placental dysfunction, in particular changes in placental nutrient delivery, contributes to many important pregnancy complications and has been linked to disease in childhood and in adult life. Very little information is available on placental phospholipid synthesis or the role of these lipids in regulating placental function and delivering essential lipids to the fetus. We expect that the results from the proposed work will ultimately lead to new understanding of the causes for placental dysfunction in pregnancies complicated by growth restriction, and maternal diabetes and could help to improve life long health of children whose development was affected by these conditions.